Deciphering the mechanisms of glia development and white matter injury

SUMMARY AND ABSTRACT
Development of myelin, the lipid sheath formed by fully differentiated oligodendrocytes (OLs), is essential for
CNS function and plays a variety of roles in supporting neuronal health and activity. Abnormalities in the
myelin sheath and subsequent neuronal impairment are responsible for the neurologic consequences of white
matter injury (WMI). Upregulation of canonical Wnt activity has been reported in patients with WMI, and
aberrant activation of Wnt signaling is an adverse event for remyelination. However, manipulating Wnt
regulators using genetic models has produced inconsistent outcomes, possibly because these Wnt components
interact with other pathways, affect transcriptional partners at different stages of the OL lineage, and/or have
Wnt-independent functions. Therefore, a critical knowledge gap is the need to understand the temporal
dynamics and molecular mechanisms underlying Wnt signaling at different stages of OL development and after
WMI. Previously, we discovered that the formin protein Daam2 (Dishevelled associated activator of
morphogenesis 2), a component of the Wnt receptor complex, suppresses OL differentiation and yet is also
required for myelination during development. These observations raise an intriguing question: how does
Daam2 play seemingly opposite roles during OL lineage development? Answering this question is essential for
devising novel therapeutic strategies for white matter disorders. To begin to answer this question, we
performed multi-omics profiling and discovered that phosphorylated Daam2 attenuates Wnt signaling in the
OL lineage and promotes OL differentiation while mitigating myelination during development. We also
identified CK2α (Casein kinase II-α) as the kinase that phosphorylates Daam2 and triggers its ubiquitin-
mediated proteolysis by the ubiquitin E3 ligase Trim28 (Tripartite motif-containing 28). Moreover, in WMI
mouse models, both CK2α and Daam2 phosphorylation were found to promote tissue repair. Based on these
compelling preliminary findings, we hypothesize that CK2-induced Daam2 phosphorylation and subsequent
degradation is a key post-translational mechanism that attenuates Wnt signaling and promotes remyelination
after injury. To address this hypothesis, we will first determine how Daam2 phosphorylation by CK2α
contributes to Wnt signaling during OL development and after WMI (Aim 1). Second, we will determine the
mechanisms of Daam2 phosphorylation-induced degradation during OL development and after WMI (Aim 2).
Upon completion, these studies will decipher the crucial role of Daam2 and its post-translational regulation in
the stage-specific OL lineage. Our findings will deliver clinically applicable insights into regulatory pathways,
potentially filling a critical unmet need for patients with WMI.

Public health relevance
PROJECT NARRATIVE A mechanistic understanding of oligodendrocyte development and myelin repair after injury will shed light on cellular vulnerability to white matter injury. In this proposal, we will define new genes and pathways that drive stage-specific oligodendrocyte lineage development and myelin repair via Wnt signaling, and pinpoint potential targetable pathways for therapies that can stimulate remyelination in white matter disorders.